A Mucus-producing Intestinal Epithelium Model for In Vitro Drug Absorption Testing

Project Summary
The mucus layer is the first line of defense against infiltration of microorganisms, digestive enzymes
and acids, digested food particles, microbial by-products, and food-associated toxins. This layer coats the interior
surface of the GI tract, lubricates luminal contents and acts as a physical barrier to bacteria and other antigenic
substances present in the lumen. The moist, nutrient-rich mucus layer adjacent to the epithelial barrier of the GI
tract is also essential in the maintenance of intestinal homeostasis and contains a thriving biofilm including
beneficial and pathogenic microbial populations. However, mucus has proven difficult to study, owing to it
compositional and functional complexity and a substantial lack of either high-quality purified samples or cell-
based culture systems containing mucus.
This project will establish a gastrointestinal (GI) model for both harvesting physiologically relevant mucus
and an epithelial culture system that possess a native mucus layer. Building on Altis’ capabilities to generate
models with greater physiological relevance using donor-derived cells, this program will establish key protocols
and workflows to ensure a reliable and reproducible mucus layer to additionally replicate in vivo GI morphology
and function. In Aim 1, we will finalize in vitro protocols for mucus production in epithelia from both the small
and large intestine (jejunum and transverse colon), which are well-described to production functionally distinct
mucus. These data will establish key quality metrics enabling Altis to explore R&D studies with our industry and
academic clients in diverse aspects of early stage of drug development and the development of inflammatory
disease and microbiome research. Based on prior discussions with our pharmaceutical development customers,
we view the commercial potential for this model as strong, especially given the unique capabilities of Altis’ current
platform.

Public health relevance
Project Narrative Mucus provides a critical component of gastrointestinal innate immunity, protecting the epithelium from infectious and noxious agents and regulating the balance of host microbiome and inflammatory responses. However, the lack of relevant mucus-related reagents and cell models has substantially limited GI-related drug development and basic research. Altis Biosystems, Inc. has developed an epithelial model that can be utilized as both a source of native GI mucus and/or an integrated cell model with a mucus layer. These models have broad applicability to drug discovery, biomaterials development, and mechanistic studies to understand disease pathophysiology.